Subjective Valuation of Physical Effort in Health and Disease

PROJECT SUMMARY
A major hurdle to compliance with rehabilitation therapies is poor effort on the part of patients, caused by
fatigue and feelings of insurmountable effort. If a physical exercise feels very effortful one may be unwilling to
exert the effort required, whereas if an exercise feels less effortful one may be more likely to persevere.
Despite the ubiquity of effort-based judgments, and their disruption in a variety of neurological conditions, the
mechanisms responsible for the subjective valuation of physical effort have received limited investigation. The
central hypothesis of this proposal is that an individual's subjective valuation of effort is reflected in her inherent
excitability of motor cortex, and that this metric is sensitive to disease state. We will perform experiments in
healthy human participants; and a group of participants with multiple sclerosis (MS). We have developed a
novel effort-based choice paradigm that allows us to obtain a precise objective measure of an individual's
subjective valuation of effort. We will use this approach, in combination with computational modeling, functional
magnetic resonance imaging (fMRI), and noninvasive brain stimulation, to investigate the mechanisms
responsible for the subjective valuation of effort. In Aim 1 we will study how motor physiology influences
subjective effort valuation in healthy participants. We will use transcranial magnetic stimulation (TMS) to non
invasively probe the physiological properties of participants' motor cortex; and we will have the same
participants make decisions about effort while they are scanned with fMRI, and use this data to computationally
model their subjective valuation of effort and associated brain activity. These experiments will allow us to test
the relationships between an individual's representations of effort value and motor physiology. In Aim 2 we will
identify the mechanisms of subjective effort valuation in patients with MS. We will use TMS and fMRI to
investigate the neural and behavioral representations of effort value in MS. These experiments will shed light
on the neural circuits that are disrupted in individuals with MS, suffering from feelings of fatigue. Our studies
will have a broad impact on the fields of decision-making and motor control by dissecting the fundamental
mechanisms responsible for physical effort valuation. This work will provide an understanding of the neural
mechanisms underlying disrupted feelings of effort in MS, and may eventually reveal neurobehavioral markers
and neuromodulatory interventions to aid in the prediction and treatment of rehabilitation non-compliance.

Public health relevance
PROJECT NARRATIVE The goal of this proposal is to understand how an individual's inherent motor cortical physiology influences their behavioral and neural representations of physical effort, and how this relationship is disrupted in patients with multiple sclerosis who suffer from feelings of insurmountable effort. The findings from this work may eventually reveal neurobehavioral markers and neuromodulatory interventions to aid in the prediction and treatment of rehabilitation non-compliance.